Study of Transcutaneous Auricular Neurostimulation as a Treatment for Alcohol Use Disorder

PROJECT SUMMARY/ABSTRACT
Alcohol use disorder (AUD) is a major health problem in the United States, often attributed to factors impacting
the mesolimbic and cortico-striatal systems in the brain. Currently, there is a pressing need for the development
of both therapeutic interventions and effective biomarkers for alcohol withdrawal syndrome (AWS) and alcohol-
related psychiatric symptoms.
One promising non-pharmacological approach is transcutaneous auricular neurostimulation (tAN), a non-
invasive neurostimulation technique that stimulates neurotransmitter systems. tAN combines vagus nerve
stimulation (VNS) and trigeminal nerve stimulation (TNS). Our study has shown that tAN is a safe and effective
non-invasive treatment for reducing substance withdrawal symptoms, particularly those from opioids, suggesting
its potential as a therapeutic tool for improving AWS. The aim is to lower a patient’s desire for alcohol use and
lessen the chance of relapse.
Furthermore, another promising avenue is the integration of neuroimaging with clinical outcomes, aiming to
establish an fMRI-based objective biomarker for AUD. Incorporating tAN into this framework allows us to go
beyond mere biomarker development, offering a unique and quantifiable therapeutic strategy.
The proposed research endeavors to comprehensively investigate the efficacy of tAN as a treatment for AWS
and the development of neuroimaging biomarkers in patients with AUD. This research initiative aims to provide
a comprehensive clinical package, offering a valuable therapeutic tool. Ultimately, this work not only advances
the application of tAN in clinical settings but also contributes significantly to the broader field of translational
medical research.

Public health relevance
NARRATIVE Alcohol use disorder is a major health problem characterized by persistent alcohol use despite negative consequences. Although current pharmacotherapies and non-pharmacological approaches are effective, only a small number of patients undergoing treatment for alcohol use disorder are prescribed medications or receive non-pharmacological interventions due to systemic barriers. This study will employ transcutaneous auricular neurostimulation to investigate clinical improvements and human brain functional connectivity alterations in patients with alcohol use disorder following the treatment.